Southeast Enrollment Center Consortium 2 (SEEC-2)

The All of Us Research Program (AOURP) is a historic effort to enable 21st century biomedical research that will benefit all persons in the USA. This study will power genetic studies of health and well-being, which will eventually deliver more precise treatments and personalized medications. A specific strength of the AOURP is the role of Regional Medical Centers (RMC/HPO), which provide their experienced staff and faculty, their resources, and their trusted relationships with patients and communities, to engage, enroll, and retain participants for the AOURP study. We have formed a consortium between the University of Miami and the University of Puerto Rico Comprehensive Cancer Center. Both institutions combined have enrolled close to 20,000 participants into AURP in the prior finding cycles. In this new award we will focus on engagement with existing participants and inform them of the continued opportunities the AOURP program has to offer. The University of Miami site will also enroll 825 participants with prior or continued opioid use disorder – this will happen with the joint support of NIDA. This study is thus part of the NIH’s Helping to End Addiction Long-term (HEAL) initiative to bolsters research across NIH to address the national opioid public health crisis and improve treatment for opioid misuse and addiction. Our experienced trained staff will use multiple measures of communication to keep participants engaged. Enrollment of participants will happen in our specialized AOURP sites and the IDEA clinic at U of Miami. With over six years of experience and a well-trained and motivated team, SEEC-2 will continue our successful engagement and enrollment strategies in the coming years.

Public health relevance
This study will support the national goals of the AOURP study, which aims to build and maintain the largest US-based population cohort, complete with EHR records and genomics. Our specific contributions will focus on enrollment participants as part of the HEAL study engaging individuals that suffer from opioid user disorder. We will further keep engaging our existing cohort of nearly 20,000 AOURP participants and continue to educate them on the benefit and changes of AOURP.